Role of a novel risk loci HAVCR2 of late-onset Alzheimer's disease in the regulation of microglial response in neurodegeneration

PROJECT SUMMARY
Recent largest GWAS identified HAVCR2 (TIM3) genetic risk factor for late-onset Alzheimer’s disease (LOAD).
Our laboratory discovered and cloned Tim3 as an inhibitory molecule that induces T cell exhaustion in cancer1.
Blocking antibodies to Tim3 are being approved for the treatment of cancer. However, we have now identified
that Tim3 is not only expressed on T cells, but also on myeloid cells and dendritic cells, where TIM3 restrains
dendritic cell function and regulate anti-tumor immunity2. In the CNS, HAVCR2 was identified as one of the top
100 enriched transcripts and is specifically expressed in both mouse and human microglia3-5, but its role and
function in microglia is unknown.
Our long-term goal is to define the role of TIM3 in regulation of microglia in neurodegeneration. We made the
following observations: 1) Tim3 inhibits microglial activation and phagocytosis: deletion of Tim3 in dendritic
cells boosted antigen presentation and we find that TIM3 also regulates microglial activation and phagocytosis;
2) TGFb-Tim3 axis regulates microglia phenotype switch in neurodegeneration: we find that TGFb is the key
driver for the induction of Tim3 and once expressed it synergizes with TGFBR to potentiate TGFB signaling, loss
of Tim3 switches M0-homeostatic microglia to an MGnD-nondegenerative phenotype; and 3) TIM3 deletion in
microglia reduces plaque burden in 5xFAD mice. These data support the genetic linkage studies and show the
importance of Tim3 in regulating disease pathology in AD by modulating microglial function. Based on these
studies, we hypothesize that TIM3 is a key regulatory molecule in microglia that inhibits their response
to neurodegeneration, migratory and phagocytic functions and thereby inhibit plaque clearance
resulting in promotion of Ab deposition, development, and progression of AD in aging brain. Based on
this hypothesis we have proposed three aims:
Aim 1: Define how TIM3 regulates phenotype and functions in 5xFAD and P301S mouse AD models. We
propose to study the effect of microglial deletion of Tim3 in neurodegeneration and brain tauopathy using the
mouse models of AD.
Aim 2: What is the role of TGFb signaling in the regulation of Tim3 expression and function in microglia
and development of AD? Since TGFb plays a critical role in maintenance of the homeostatic phenotype in
microglia, we propose to study how TGFb signaling induces Tim3 expression and promotes homeostatic
behavior of microglia by cooperating with TGFb receptor signaling.
Aim 3: Define the role of TIM3 in the regulation of human microglial function in AD. Determine how TIM3
impacts human iPSC-derived microglia activation and functions. We will examine whether genetic or
pharmacologic inhibition of TIM3 has a similar effect on iPSCs-derived human microglia expressing the MGnD
phenotype by utilizing a humanized chimeric mouse model of AD for treatment with human anti-Tim3 antibody
IN SUMMARY, targeting TIM3 in microglia may provide a novel approach for therapeutic modulation of innate
immunity in AD and dementia.

Public health relevance
PROJECT NARRATIVE This application will investigate HAVCR2 (TIM3), recently identified genetic risk factor for late-onset Alzheimer’s disease, as a target to modulate microglial function and regulate development of Alzheimer’s disease (AD). We identified TIM3 as a key inhibitory molecule in microglia that inhibits their function resulting in progression of AD. Therefore targeting Tim3 in microglia can restore microglial functions and promote clearance of Ab plaques in animal models of AD. The outcomes of the project will have considerable impact on both advancing the basic science of AD and novel TIM3-based immuno-modulating approach for the treatment of AD.